Targeting Androgen Receptor and PARP for Synthetic Lethality in CRPC

PROJECT SUMMARY (Project 3)
Metastatic castration-resistant prostate cancer (mCRPC) remains an incurable disease for which novel
molecular mechanism-based combination therapy strategies are needed. We identified an androgen receptor
(AR)- and c-Myb–co-regulated DNA damage response (DDR) gene signature that is highly correlated with
castration-resistance, metastasis, and reduced overall survival in mCRPC patients. In this DDR gene signature
homologous recombination (HR) DNA repair genes and HR modulator (HRM) genes are highly represented.
The relatively large percentage of HR/HRM genes in the DDR gene signature underscores the importance of
this group of genes to prostate cancer progression. Our preliminary preclinical studies demonstrated that
enzalutamide (ENZ), a 2nd-generation anti-androgen that blocks androgen from binding to the androgen
receptor (AR), suppressed the expression of a majority of the HR/HRM genes and synergized with olaparib
(OLA), a poly(ADP-ribose) polymerase 1 (PARP1) inhibitor in suppressing prostate cancer growth. Previously,
OLA has been associated with synthetic lethality in multiple malignancies with BRCA1/2 or other HR gene
deficiencies and its target, PARP1, plays a crucial role in base excision repair (BER) and was reported to
function as an AR co-factor. In this project, we propose to test the hypothesis that targeting AR (ENZ) and
PARP (OLA) in a “lead-in” strategy will generate synthetic lethality in mCRPC through ENZ-mediated
downregulation of HR/HRM gene activity and OLA-mediated suppression of PARP’s enzymatic activity
in BER and PARP’s cofactor role of AR transcriptional activity. The lead-in trial design will allow us to
efficiently determine the clinical relevance of our biological findings by linking baseline to sequential
modulation of target genes in individual cancers. We will test this hypothesis in three specific aims.
Aim 1. Characterize the HR/HRM gene signature in bone marrow biopsies of men with mCRPC treated with
enzalutamide and/or abiraterone, novel inhibitors of androgen signaling.
Aim 2. Further characterize the synergistic potential of and identify predictive biomarkers of response to
combination therapies that co-target AR (ENZ) and PARP function (OLA) using preclinical models.
Aim 3. Conduct a clinical trial of treating CRPC patients with ENZ followed by the addition of the PARP
inhibitor OLA to achieve greater therapeutic response and to correlate an ENZ-regulated HR/HRM
gene signature to the therapeutic responses.

Public health relevance
PROJECT NARRATIVE (Project 3) The results of our proposed studies will (1) define a panel of HR/HRM genes that predict clinical response of mCRPC to novel AR-signaling inhibitors and 2ndgeneration anti-androgens; (2) select specific HR/HRM expression-based biomarkers for ENZ, OLA and ENZ+OLA therapy to stratify CRPC patients for maximum benefit in clinical trials; and (3) conduct a clinical trial that will provide greater therapeutic benefit and correlate selected biomarkers to tumor response. Overall, the results of these studies will establish predictive biomarkers and a novel mechanistic framework for the optimization and use of the combination of ENZ and OLA to treat mCRPC.